Mentoring alcohol use intervention research in health care settings (administrative supplement)

Abstract
Background and Rationale. Unhealthy alcohol use plays a major role in extending the HIV
epidemic, and there is urgent need to develop effective alcohol interventions and train diverse
researchers. With current K24 support from NIAAA, Dr. Derek Satre, Professor in the University
of California, San Francisco (UCSF), Department of Psychiatry and Adjunct Investigator in the
Kaiser Permanente Northern California (KPNC) Division of Research, has developed a strong
research and mentoring program in studying alcohol interventions in HIV care settings. Within
the scope of his K24 aims, this supplement will enhance mentoring, career development, and
research on health disparities that impact people with HIV (PWH) from minority groups as well
as women and young adults, issues of heightened urgency during the COVID-19 pandemic.
Mentoring and Training. Dr. Satre proposes to enhance his mentoring of new scientists by
collaborating with the Center for AIDS Prevention (CAPS) Visiting Professor (VP) program;
working with VP Program faculty to further integrate alcohol research training. The VP Program,
affiliated with the UCSF Center for AIDS Research and AIDS Research Institute, assists
investigators (primarily minority scholars) already working in minority communities in the US.
VPs will work with Dr. Satre on analysis of disparities-focused alcohol research at KPNC (and
potentially other projects using health system data), and will be offered alcohol-focused training
opportunities. This supplement will also support formative work, including participation of
leading alcohol and HIV researchers as consultants, in developing a strategic plan to further
enhance alcohol training in the CAPS VP Program long-term. Dr. Satre’s career development
will benefit from collaboration with CAPS faculty and consultants included in this supplement.
Research Plan. Building on Dr. Satre’s ongoing work with large KPNC HIV and alcohol use
data sets, the proposed research integrating CAPS VPs will examine racial/ethnic and sex-
based differences in patterns of comorbid unhealthy drinking, substance use, mental health
symptoms; routine primary care-based preventive services, access to mental health and
addiction treatment services, and their relationship to HIV care continuum outcomes.
Summary. The proposed K24 administrative supplement will enhance the current award by
strengthening Dr. Satre’s mentoring opportunities and ability to address health disparities, offer
opportunities in alcohol and HIV research to underrepresented scholars, and complete
important analyses within this scope of the original K24 aims; and lay the groundwork for
additional alcohol focused HIV treatment and prevention research training.

Public health relevance
Project Narrative Unhealthy alcohol adversely impacts HIV care and is strongly associated with psychiatric disorders and drug use, and COVID-19 has exacerbated these interrelated problems. There is an urgent need to train diverse treatment researchers, especially those working in minority communities in the US. This K24 administrative supplement application builds on a successful program of research to improve HIV care, examine HIV care disparities, and enhance mentoring opportunities for minority trainees and junior faculty scientists in alcohol and HIV treatment research.